Heparan sulfate proteoglycan in the brain vascular clearance of amyloid-β and Alzheimer's disease

PROJECT SUMMARY
Alzheimer`s disease (AD) is a progressive degenerative disease of the brain, a dementing illness associated
with early neurovascular changes and the accumulation of misfolded amyloid-β (Aβ) and tau in the brain. At
present, no effective treatment is available to slow or halt the progression of AD. Hence, uncovering novel
mechanisms that govern AD pathogenesis may advance the development of more effective therapeutic
strategies to treat this devastating disease. Mounting evidence suggests that the accumulation and aggregation
of Ab in brain parenchyma and cerebral blood vessels (CBVs) is a key event leading to other AD-related
pathologies. Kinetic studies in patients with sporadic AD indicate that faulty Aβ clearance, rather than Aβ
overproduction, is critical for accumulation and aggregation of Aβ in brain. However, the molecular
underpinnings of such Aβ accumulation remain poorly understood. Our preliminary studies indicate that heparan
sulfate (HS), a type of sulfated polysaccharide that critically mediates cell-cell and cell-matrix interaction and
signaling, is strongly reduced in CBVs of AD patients. In this application, we will test our novel hypothesis that
HS expressed in CBVs normally facilitates the clearance of Ab out of the brain and that such function is disrupted
in AD, leading to impaired Ab clearance. Mechanistically, we hypothesize that HS maintains CBV integrity,
functions as a co-receptor in LRP1-mediated Ab clearance and facilitates perivascular Ab elimination. We will
pursue the following 3 specific aims to rigorously test our hypothesis: 1. Elucidate the roles of brain endothelial
cell (bEC) HS in Ab clearance and test the hypothesis that increasing bEC-HS expression normalizes Ab
clearance to mitigate AD pathogenesis. 2. Delineate the molecular mechanisms underlying the roles of bEC-HS
in brain Ab clearance and AD pathogenesis. 3. Elucidate the roles of brain vascular smooth muscle cell (bVSMC)-
HS in brain Ab clearance and AD pathogenesis. These proposed studies exploit both novel and established
genetic, cellular, scRNA-seq and biochemical approaches in conjunction with human AD specimen and AD
mouse models. The results of this study are expected to illuminate HS expressed in CBVs serves as a key
molecule to mediate brain Ab clearance and decreased CVS-HS expression exacerbates AD, and will provide
in vivo evidence for the proof of principle that increasing bEC-HS is an effective intervention to mitigate AD
pathogenesis.

Public health relevance
PROJECT NARRATIVE This proposal is highly relevant to public health as the proposed studies are expected to elucidate the pivotal roles and underlying cellular and molecular mechanisms of the heparan sulfate expression in Aβ clearance and AD pathogenesis, which likely will contribute to the development of novel therapeutics for AD treatment.